Admin Core

PROJECT SUMMARY: ADMINISTRATIVE CORE
All three Partnering institutions, Morehouse School of Medicine (MSM), Tuskegee University (TU), and the UAB
O’Neal Comprehensive Cancer Center (UAB OCCC), have established Administrative Cores. As part of the
currently active U54, efficient administrative infrastructure is in place at each of the three institutions. This core's
primary objectives are for coordination, communication, budgetary oversight, and clerical functions associated
with the overall research program proposed in this grant application. The Partnership has four Cores
(Administrative, Outreach, Planning and Evaluation, and Research Education), Research Projects (two Full
Projects and a Pilot Project), and two Shared Resources (Bioethics and Biostatistics/Bioinformatics). The
Partnership Administrative Core, which is responsible for administrative management of Partnership-wide
activities, is comprised of the institution-specific Executive Committees (ECs), the Partnership Leadership
Committee (PLC), the Internal Advisory Committee (IAC), and the Program Steering Committee (PSC). The
ECs, consisting of all institution-specific Principal Investigators (PIs) (contact-PI, MPIs, and Co-Leaders of all
cores and shared resources), meet once a month and are responsible for the day-to-day oversight at each
institution. The PLC, consisting of the PIs and co-leaders of all three institutions, as in the past, will have a
monthly teleconference and will be responsible for internal planning, execution, and assessment of the
Partnership activities. The IAC, consisting of six leaders (two from each Partnering institution), reviews, twice a
year, the Partnership’s progress and decisions and guides the overall Partnership. The PSC, consisting of five
external members, whose expertise covers all areas of the proposed research programs, and an NCI-official as
an ex-officio member, functions as the external review body, which annually evaluates all components of the
Partnership’s progress and provides guidance. Further, together with Planning and Evaluation Core, a Scientific
Review Committee, consisting of all PIs and a science editor, will solicit pilot projects to be funded in years 4 and
5 of the funding cycle and assigns them to external reviewers to assess their scientific merit and funds them after
obtaining approvals from PSC. The expertise of the PIs of all three institutions is complementary to each other,
and most of these leaders have been productively working together for more than 10 years. Together with
Administrative/Finance Officers of the respective institutions, the Program Managers aid the Partnership by
providing day-to-day administrative support, coordination, preparation of the annual progress reports, and
logistical services needed to accomplish the Partnership functions. Additionally, the Presidents and PIs of all
three institutions will continue to conduct yearly joint video conferences to discuss progress of the Partnership
and to reaffirm their continued commitment to strengthen, integrate, and expand Partnership activities.